Center for Systems Neurogenetics of Addiction

PROJECT SUMMARY OVERALL
The Center for Systems Neurogenetics of Addiction (CSNA) leverages approaches and expertise in behavioral
neuroscience, computational science, genome biology, mouse and human genetics, and genetic engineering to
identify, contextualize and model shared and distinct biological mechanisms of biobehavioral risk for cocaine
self-administration. Drug addiction is a devastating and complex disorder influenced by multiple etiological
factors. Extensive evidence demonstrates the role of genetic variation on a range of addiction behaviors, from
experimentation and initiation of drug use to compulsive drug-taking behavior. Yet discovery of predisposing
genes and variants in human populations is limited by high sample size requirements, phenotyping capacity, and
variability in drug exposure and other environmental factors. Advanced mouse genetic populations exhibit
variation in addiction-relevant behaviors and offer an experimental platform to discover the neurobiological
mechanisms by which predisposing traits predict the tendency to self-administer cocaine. The CSNA employs
the Collaborative Cross genetic reference population and Diversity Outbred mapping population across three
integrated research projects focused on three interrelated aspects of addiction susceptibility: impulsivity, cocaine
sensitization and self-administration. These traits are evaluated using a multidimensional phenotyping platform
in a mouse population exhibiting extreme genetic and phenotypic variation, enabling a replicable and extensible
assessment of the shared and distinct biological mechanisms of addiction vulnerability. These complementary
populations are derived from the same founder strains, allowing for extensive data integration across studies
within and outside the CSNA. The CSNA develops data integration methods and produces multiple functional
genomics and phenomics datasets, deposited in widely accessed and highly functional informatics resources for
the global research community. The Center also extends its results into basic neurobiological and preclinical
therapeutic research by integrating findings with human genetic and genomic studies, generating novel, validated
mouse mutants and identifying vulnerable and resistant strains for mechanistic studies. Three research support
cores provide state-of-the-art approaches to the CSNA research projects and the larger research community,
including a sophisticated, large-capacity Behavioral Phenotyping Core, an Integrative Genetics and Genomics
Core for statistical genetics, molecular profiling, biobanking, data integration and data dissemination, and a
Mouse Resource and Validation Core for creating and delivering novel mouse resources for systems genetics,
validation, and disease modeling. The Administrative Core coordinates, integrates, and disseminates research,
education and outreach activities. Finally, a Pilot Core enables collaborative work to promote innovation and
diversity in addiction science. Through its combined efforts, the CSNA will have a lasting impact on the study of
addiction genetics through the holistic examination of biobehavioral risk, the generation of community data
resources that we and others will expand and exploit in future studies, and through education and training.

Public health relevance
RELEVANCE TO PUBLIC HEALTH (PROJECT NARRATIVE) OVERALL The Center for Systems Neurogenetics of Addiction (CSNA) seeks to identify the biological relationships among the stages and patterns of cocaine addiction and behaviors that predict drug abuse. To uncover these relationships, we will make use of advanced mouse genetic tools that allow us to precisely and efficiently identify the genes related to addiction, and computational methods that enable holistic study of genes, biological molecules and behaviors. We will discover addiction-related genes, but we will also generate enabling resources and services for the addiction research community to unravel the complexity of addiction risk.